Paradigms of maintaining anterior segment homeostasis

Project Summary/Abstract
Inflammatory responses in the eye, such as following corneal wounding, and in autoimmune-mediated uveitis,
must be controlled and resolved to preserve homeostasis and prevent damage. In all these conditions, we
discovered that immune cells are recruited to the surface of the lens, many with characteristics associated with
immunomodulation. The central location of the lens and its interface with most eye tissues via the adjacent
aqueous and vitreous humors places it in the perfect position for these Lens Capsule Associated Immune
Cells (LC-AICs) to present antigens and produce proteins that can exert immunosuppressive functions across
the eye. In addition, we found that there are resident immune cells, the sentinels of the immune system, that
become integrated within the lens during development. We now build on these findings with studies aimed at
understanding the lineage and functions of lens resident immune cells and LC-AICs recruited from other ocular
sites, their roles in maintaining homeostasis, and whether their long-term persistence is linked to pathogenic
outcomes. In Aim 1, we will perform lineage tracing studies to determine their ontogeny. These studies will
reveal whether these immune cell populations are long-lived, self-renewing and embryonic yolk-sac derived, or
short-lived, bone marrow-derived typical of those recruited to tissues in response to injury and pathogenesis.
Since tissue resident immune cells are immediate responders to injury and pathogenesis, we will investigate
whether their activation in response to corneal wounding is linked to LC-AIC recruitment and regenerative
repair of the cornea. In Aim 2, we will perform a detailed analysis of the immunomodulatory properties of the
LC-AICs recruited to the lens post-corneal wounding and in uveitis. These studies will include a functional
analysis to directly link the LC-AICs to the suppression of T-cell activation. We also examine the anti-
inflammatory and anti-angiogenic properties of the bioactive matrix-derived molecules proteolytically released
by LC-AICs as they migrate within the lens capsule. Our studies of the LC-AICs strongly support their
important functions as immunomodulators in the eye, including our discovery that they persist integrated with
the lens surface during the resolution of inflammation in uveitic eyes. However, their long-term persistence at
the lens capsule surface beyond this time, and the ability of a subset to abrogate lens immune privilege and
infiltrate the lens, suggests that their prolonged presence could lead to pathological outcomes. In Aim 3, we will
determine the mechanisms by which LC-AICs cross the lens capsule to infiltrate the lens and their fate,
including whether they can be agents of cataractogenesis by becoming collagen I-producing myofibroblasts. In
addition, we will investigate the properties of the fibrillar network with which the LC-AICs maintained on the
surface of the lens become entwined, and to which the iris becomes attached at late stages of uveitis, which
could be linked to pathological outcomes of uveitis. Understanding these links could lead to new treatment
options for patients with ocular pathologies associated with chronic inflammation.

Public health relevance
Project Narrative We have discovered that the immune privilege status of the avascular tissues in the anterior segment has led to a unique response to eye trauma, injury and pathogenesis that involves the activation and recruitment of immune cells to the lens for the purpose of preserving/restoring homeostasis. With lineage tracing studies we will identify the ontogeny of lens tissue resident immune cells and of the immune cells recruited to the lens in response corneal wounding, and determine their immunomodulatory functions in maintaining anterior segment homeostasis following corneal wounding as well as in the inflammatory disease uveitis. We also will examine the potential harmful outcomes of the persistence of these lens associated immune cells in the development of eye pathologies including cataract and glaucoma.